Integrative Treatment for Achieving Holistic Recovery from Comorbid Chronic Pain and Opioid Use Disorder

Project Summary
The Parent Grant, the UNM IMPOWR Center (University of New Mexico Integrative Management of chronic
Pain and Opioid use disorder for Whole Recovery; RM1DA055301; mPIs Witkiewitz, Pearson), seeks to utilize
a holistic approach to assess and treat biopsychosocial factors that contribute to pain and opioid use disorder
(OUD), and improve the lives of diverse individuals with chronic pain and opioid misuse/OUD in diverse
communities. UNM IMPOWR has two major research projects. The HOPE Trial is a multisite effectiveness-
implementation trial investigating the effectiveness of an integrated treatment for chronic pain and OUD
(Acceptance and Commitment Therapy [ACT] and Mindfulness-Based Relapse Prevention [MBRP]). The
OPTIC Trial uses community-based participatory research (CBPR) methods to develop a culturally centered
intervention for chronic pain and OUD in American Indian/Alaska Native primary care clinics based on Native
American Motivational Interviewing. UNM IMPOWR has also convened a community advisory board and
scientific advisory board to help guide program development, implementation, and to maximize research
impact. The research aims of the diversity supplement are to 1) begin the process to culturally center two
integrated treatments for chronic pain and opioid use disorder (Acceptance and Commitment Therapy and
Mindfulness-Based Relapse Prevention) for Hispanic/Latino/a/x individuals in the United States; 2) examine
acceptability, feasibility, and compliance rates of an ecological momentary assessment study of pain, cognitive
defusion, craving, mindfulness, and distress tolerance ; and 3) evaluate the degree of within- and between-
subject variability in constructs of interest including pain, cognitive defusion, craving, mindfulness, and distress
tolerance. The training aims of the supplement are to 1) acquire training in community-based participatory
research; 2) acquire training in psychosocial treatments for opioid use disorder; 3) obtain experience in
advanced quantitative approaches for longitudinal and intensive longitudinal data; 4) receive training in
qualitative research methods and qualitative data analysis; and 5) receive training in manuscript production,
research dissemination (e.g., posters, symposia), writing NIH grant applications, and the responsible conduct
of research. Ultimately, the overall training and research experiences will prepare Dr. Schwebel to become a
successful independent researcher examining chronic pain and OUD.

Public health relevance
Project Narrative This project seeks to provide training to Dr. Frank Schwebel in community-based participatory research and ecological momentary assessment to begin to culturally center Acceptance and Commitment Therapy and Mindfulness-Based Relapse Prevention for individuals with chronic pain and opioid use disorder. This supplement will train the applicant in community-based participatory research, psychosocial treatments for opioid use disorder, qualitative research methods and analyses, and advanced quantitative methods. The results from this project will be used to inform grant submissions focused on developing mobile health treatments for individuals with chronic pain and OUD and on culturally centering chronic pain and opioid use disorder treatments for Hispanic/Latino/a/x individuals.